Investigation of regulatory cascades governing development of the outflow structures of the eye

Anterior segment dysgenesis (ASD) is a developmental anomaly of the eye that can involve multiple
tissues including the cornea, iris, lens, ciliary body and ocular drainage structures including the trabecular
meshwork (TM). As a result, ASD is associated with an increased risk of glaucoma and corneal opacities. In
fact, glaucoma will arise in 50% of patients with ASD due to disruption in aqueous humour drainage, which
leads to an elevation in intraocular pressure (IOP). Malformation of structures in the anterior segment of the
eye is thought to occur due to a defect in the differentiation and migration of the periocular mesenchyme
(POM), a derivative of neural crest. Although inappropriate patterning of the POM is strongly implicated in
ASD, the mechanisms of POM function and/or disruption in ASD are unclear. Our laboratories have shown that
activating transcription factor β (AP-2β) is highly expressed in the POM and POM-derived tissues of the post-
natal mouse eye. During the previous funding period we created two mouse models in which Tfap2b (the gene
encoding AP-2β) was conditionally deleted in the POM. These models both exhibit features reminiscent of
human ASD and glaucoma. However, one model presents with complete iridocorneal adhesion, and the other
with a partially closed angle phenotype, yet in both models the TM region is severely affected. We further
utilized one of these models to identify important, candidate downstream genes of AP-2β that likely impact
development of anterior eye structures. The current proposal aims to employ these novel models to further
determine how loss of function of AP-2β results in developmental defects and alterations in downstream
regulatory networks that control formation of the anterior angle structures of the eye, which are critical in
managing aqueous outflow. Thus, our overarching hypothesis is that AP-2β-regulated genetic cascades in
the POM are essential for governing development of the ocular structures in the anterior segment of
the eye that maintain IOP homeostasis. In the current proposal we will continue to utilize conditional KO
approaches in mice to identify the individual role(s) that the AP-2β gene plays in development of the anterior
angle tissues including the TM. We will also use state-of-the-art “omics” level analyses to determine the
patterns of normal gene expression in the anterior segment and how they are disrupted by loss of Tfap2b.
Finally, we will further assess the glaucomatous changes observed in the mouse models generated to further
understand the pathophysiology of closed angle glaucoma and optic neuropathy.

Public health relevance
The anterior segment of the eye has a number of functions in regulating vision, including the production and drainage of the aqueous humor, a fluid that is needed to nourish ocular tissues. Disregulation of this aqueous humor flow can occur if there are defects in the anterior segment that prevent drainage, such as ocular tissues that are adhered to one another inappropriately to give a closed angle or blockage in the drainage of the eye at a filter termed the trabecular meshwork. Such blockages cause a rise in intraocular pressure (IOP) that frequently results in glaucoma, a common eye disease that causes loss of retinal function and is one of the leading causes of blindness in the US, as well as worldwide. In this project, we will assess how a critical gene encoding the transcription factor AP-2β, which is implicated in human glaucoma, normally regulates development of the anterior segment of the mammalian eye, as well as how its loss results in eye pathology including structural defects, raised IOP, glaucoma and optic neuropathy. !